Deciphering Male- and Female-coordinated Gating Mechanisms that Ensure Plant Reproductive Success

Reproduction in flowering plants depends on multiple male (pollen)-female (pistil) interactive steps to
deliver sperm, which are non-motile and transported as cytoplasmic cargos by the pollen tube through
several specialized pistil tissues to the female target for fertilization, leading to seed production. The
proposed research addresses key cell-cell communicative events in three distinct prezygotic (i.e. prior to
sperm-egg fusion) phases during the pollen/pollen tube journey in the pistil to enable fertilization. Long-
term efforts in our lab have set discovery milestones for the field and recently elucidated key molecular
players in each of these phases, providing critical advances and unprecedented opportunities for the
mechanistic dissection proposed here. The pistil supports pollen germination on its receptive surface, the
stigma, to produce a pollen tube that grows inside the transmitting tissue to reach the target egg-bearing
chamber, the female gametophyte located inside an ovule. Once arriving at the female gametophyte, the
pollen tube burst, releasing sperm for fertilization, producing seed. The pistil also set up barriers to ward
off unwanted mates or invasive disease agents, and to effectively prevent multiple pollen tubes from
penetrating the same female gametophyte to suppress polyspermy and ensure progeny health. We
discovered three related signaling modules, each critical for one the three prezygotic phases. Phase 1
supports pollen germination on the stigma. Phase 2 achieves two goals, one ensuring pollen tube integrity
until it reaches its target, the other ensuring single pollen tube entry into an ovule. Phase 3 occurs at the
pollen tube/ovule and pollen tube/female gametophyte interfaces. Interactions here induce bursting of
the first-arriving pollen tube in the female gametophyte and trigger a mechanism for a local polyspermy
block to further ensure against supernumerary pollen tube entry into an already penetrated female
gametophyte. These signaling modules are anchored by the pistil-expressed receptor kinase FERONIA
or pollen-expressed homologs, each partnering with a GPI-anchored protein (GPI-AP) LORELEI (LRE)
or LRE-like GPI-AP1,2,3 (LLG1,2,3) to serve as coreceptors for peptide ligands called RALFs (Rapid
Alkalinization Factors). Here we propose experiments to elucidate how these signaling modules and
additional regulatory factors impact the molecular interactions, biochemical processes and cellular
conditions in pistillate cells to mediate success for these prezygotic phases, enabling fertilization, and to
prevent unwanted intrusions. Plants have evolved but hidden in the most protected location these highly
sophisticated cell-cell communication strategies to ensure their own proliferation. Our expertise positions
us uniquely capable of achieving these goals, which will fill a complete mechanistic void, setting
paradigms to guide studies in many ecologically and agriculturally important plants, and inform rational
designs to safe-guard reproductive success, ensuring food security to provide for global nutritional needs.

Public health relevance
Request Justification The parent award (R01GM147548-01A1) has a heavy reliance on microscopy. Our overall research goal has not changed and our access to high-end microscopy (point-scanning, high-resolution, multi-photon) in our campus’ Light Microscopy Core Facility (LMCF) has not changed. The Supplemental request is for a replacement of our 27-year-old microscope (a NIKON E800, purchased in 1996 on NIH GH52953). The E800 has been a workhorse and contributed heavily to my entire portfolio of publications with a cell biological orientation (the most relevant to the project is listed in my Biosketch), including a new paper in Cell, listed as the last entry in my Biosketch. There have been many generations of microscopes marketed by NIKON since the E800. While we coped the best we could with out-dated technology, the functionality of our microscope has been on a slow decline over the past decade due to increasing difficulty in acquiring replacement parts. In the last service call (January 2023), I was warned the E800’s capability would continue to decline to below the limits of operational needs (such as moving shutters in and out, filter turrents etc.; yes these are all in manual mode). The requested microscope will provide hours of access for training and pilot experiments prior to using the LMCF facility, which charges by the hours on all microscopes. Our original budget has depended on the E800 (located just steps from my office and lab). Declining ability to do so translates to a full reliance on the LMCF (hourly users-fees are set between $22.05–$26.25 for point-scanning confocals, and $33.60 for multi- photon). The added costs will be unsustainable. It will also incur extraordinary hardship for the many hours of on-hand training (typically provided by the PI and a senior trained personnel, to postdoc) needed to initiate each new trainee. Research strategy The goal is to achieve the originally planned research using the requested microscope (a NIKON Ti2-E microscope with CREST V2 spinning disc components). The new microscope will be many generations advanced from the NIKON E800 and the added spinning confocal capability will provide an enhanced imaging capability before advancing to the microscopes in the LMCF. Proposed activities: A. Pollen and pollen-derived molecular trigger-induced stigmatic cell responses to initiate pollen hydration and germination. Figs. 1, 2 are examples of how we shall meet our imaging needs. • Typically (Fig. 1A), we monitor hydration for 10-30 minutes (Wildtype completes in 10, mutants take longer). We use epifluorescence to monitor the rise or fall in nitric oxide (NO) or ROS (not shown), which do not require the resolution of confocal imaging, but extended time on the microscope. The next is pollen tube emergence and penetration of the stigmatic papilla cell (Fig. 1B). This relies on confocal imaging. Fig. 1B shows one hr after pollination, when a pollen tube is seen attached to a papilla cell. The goal is to monitor pollen hydration and tube germination with papilla cell responses [revealed by, e.g., Ca2+, water channel (see Fig. 2) cell wall quality reporters] over the time course. The requested microscope will provide on-hand training for students and collect preliminary observations for the optimal time frame for each response to guide the more refined imaging needs at the LMCF. Fig. 1A. (upper) Wide-field imaging of stigmatic NO response upon pollination. (Lower) Bright-field, time course of wildtype pollen hydration from time of deposition to full hydration (published). Fig. 1B. Point- confocal scanning image of a germinating pollen tube (acquired in LMCF). New student acquired images. • Fig. 2 (next page) shows how we shall examine stigmatic cell responses to pollen-derived molecular trigger (pollen coat protein-Bγ, PCP-Bγ) partially on the requested microscope (Fig. 2A) and partially at the LMCF (Fig. 1B). Typically, and using Ca2+ dynamics as an example, we screen the efficacy of recombinant molecules by bright-field (top) and epifluorescence (bottom) (Fig. 2A, the green fluorescence shows extracellular Ca2+, reflecting efflux from the papilla). The determined optimum reagent, dosage and time frame (requiring considerable microscope time) will inform on experimental conditions used for confocal microscopy to acquire refined data (Fig. 2B, acquired by point-scanning confocal at the LMCF). • Fig. 2C shows how the trigger PCP-Bγ had impacted the activation (reflected by higher plasma-membrane intensity of the probe aquaporin- Cherry). The images were acquired on a Crest V2 demo session. The proof of principle experiment provides solid support and justification to move forward to higher spatial resolution point-scanning confocal or high-resolution STORM microscope at the LMCF. The savings based on using the requested microscope will allow higher qualitative and quantitative achievements. Fig. 2A (legend). Pollen trigger PCP-Bg induced Ca2+ efflux from papilla cells. Co-imaging (upper, bright-field; lower, epifluorescence). Pilot experiments to establish MBP-PCP-Bg has higher efficacy. Fig. 2B. Point-scanning confocal image of MBP-PCP-Bg-triggered papilla cell Ca2+ efflux, permitting considerably higher resolution details. Fig. 2C. PCP-Bγ-induced enhance membrane association of aquaporin, facilitating water transfer to hydrate deposited pollen grains. Acquired by a demo on CREST V2. B. Another goal of the parent grant is to reveal how the target female cells respond when pollen tubes approach, arrive, penetrate and burst to release sperm for fertilization. We can refine the temporal and spatial windows (e.g., see Fig. 3A,B, under semi-in vivo condition where access to imaging is easier), which takes a lot of time, on the requested microscope. The we migrate to the LMCF to monitor detailed dynamics of ovule responses. Fully in vivo experiments are even more challenging. Fig. 3C shows a typical time course for in-vivo pollination. Typically, we establish the pollen tube front (arrow) migration rate using the requested microscope. The information will inform on how to set up higher-resolution experiments that monitor the female cell dynamics during pollen tube entry and burst with the microscopes in the LMCF. Fig. 3. (A) Pollen tube growth and targeting under semi-in vivo conditions. (B) Monitoring the process over three to four hours from the start of observation till completion of pollen tube burst and sperm release in our basic set up for these experiments. these were acquired by the E800 a couple of years ago. (C) typical preliminary experiments to define the pollen tube front achievable in the E800 and will be done on the requested microscopes. C. Training and maintenance plan. Four frequent users (currently one senior research associate, 3 graduate students) and 3-4 new trainees (1 new graduate student, 3 undergrads) will be initiated on the microscope. The PI and senior research associate (Dr. Mingche Liu) will be responsible for training; Dr. Liu will be charged with upkeep duties and training of students on general equipment care after each use. The proximity of the requested microscope to the lab and PI’s office allows close supervision at the beginning and drop-in help and consultations as needed. We will also have access to consultation with the LMCF staff as needed and for transition to use the facility there. After the initial warranty (five years on the microscope, 1 year on electrical and third-party parts), service contracts will be financed partially by a budget allocation from the parent grant and partially from departmental contribution based on the lab’s research activities. We anticipate a low level of sharing (< 10%) from departmental colleagues’ labs; their use will be prorated towards a contribution for service expenses.